Spatially resolved multi-omics profiling of human hippocampus in Aging and Alzheimer's Disease

Project Summary
Human hippocampus is among the most complex tissue types with a wide range of cells organized in spatially
precisely defined regions. Alzheimer’s disease (AD) is one of the diseases strongly affected the hippocampal
region, which underlies the core feature of the disease-memory impairment and remains refractory to therapy,
due in part to the complexity of gene regulatory network coupled with cell-type-specific mechanisms of AD
progression. What types or subtypes of cells are affected by this process and their spatial heterogeneity in the
tissue context as well as how these cells impact the tissue environments remain poorly understood, which
precludes the development of strategies to target these cells to improve healthspan/lifespan or harnessing
these cells to promote tissue remodeling and repair, highlighting a pressing need for tools to map cells and the
surround microenvironments in these tissues and generate biomarkers to define spatial and phenotypic
heterogeneity in AD. This grant aims to (1) develop a first-of-its-kind technology for spatial co-profiling of
epigenome, transcriptome, and a panel of proteins in the same tissue section, and (2) deploy the high-resolution,
high-content and high-throughput spatial multi-omics technologies to construct comprehensive maps of cellular
states and the associated environments in human hippocampus from AD patients and health donors. The
expected outcomes and the major contributions of our project include: (1) Fundamental knowledge on diverse
cell types and their molecular basis of selective vulnerability (and conversely the resilience of other cell types) in
the context of tissue organization in the AD human hippocampus, allowing us to develop a
high-spatial-resolution cell census which will in turn allow us to identify molecular signature patterns, gene
regulatory networks, and biological processes potentially mediating cell type specific differences in the AD, and
(2) Offer the possibility of testing new therapeutic approaches for AD that are not targeted by currently approved
treatments. The resulting data will lead to better understanding of the relationship between tissue organization,
function, and gene regulatory networks in AD.

Public health relevance
Project Narrative This project aims to develop a scalable and transformative technology for spatial co-profiling of epigenome, transcriptome, and a panel of proteins in the same tissue section, and deploy the high-resolution, high-content and high-throughput spatial multi-omics technologies to construct comprehensive maps of molecular and cellular events, and the associated environments underlying the etiology of Alzheimer’s disease as opposed to normal aging. It will improve our understanding of the relationship between tissue organization, function, and gene regulatory networks in AD.